SCH: SciML-Accelerated Cardiovascular Digital Twins for Personalizing Long-Term Heart Valve Interventions

Valvular heart diseases, such as mitral valve regurgitation, significantly impact patient health and require
personalized therapeutic strategies for long-term success. Current interventions involve valve repair or
replacement through surgical or minimally invasive procedures aimed at restoring normal valve function.
However, optimizing these treatments for individual patients remains challenging due to the complexity of
cardiac and valvular mechanics. Although computational modeling, particularly finite element analysis,
has enhanced ou r understanding of cardiovascular dynamics, its computati onal intensity limits practical
use in real-time clinical decision-making and long-term patient monitoring. This research aims to advance
personalized cardiovascular care by developing a rapid, predictive, and adaptive digital twin technology
capable of forecasting heart valve disease progression, optimizing interventions, and improving
therapeutic outcomes. Our central hypothesis is that integrating advanced scientific machine learning
(SciML) with computational modeling will substantially accelerate simulation speeds, enabling fast and
predictive modeling of cardiac biomechanics, hemodynamics, and fluid-structure interactions (FSI), which
are essential for long-term optimization of heart valve interventions. To achieve this, we propose
developing a neural network finite element (NNFE) framework to significantly accelerate complex
multiphysics heart valve simulations for adaptive, personalized treatment planning. Specifically, Aim 1
focuses on developing an efficient neural network-driven FE model for structural cardiac mechanics and
valve dynamics, while Aim 2 extends this NNFE technology to simulate multiphysics cardiovascular
interactions involving patient-specific hemodynamics. Aim 3 integrates these NNFE models into a
comprehensive digital twin platform ta rgeting mitral valve regurgitation, assessing the effectiveness of
Transcatheter Edge-to-Edg e Repair (T
E
E
R), and examining the impacts of pre- and post-operative valve
geometry, mechanics, and blood flow on long-term clinical performance. Ultimately, the proposed heart
valve digital twin will enable clinicians to predict disease progression, optimize valve interventions, and
improve patient outcomes. This project represents a transformative advancement in personalized
medicine, aiming to improve healthcare delivery, reduce costs, and enhance the quality of life for
cardiovascular patients.
RELEVANCE (See instructions):
Heart valve disease is a serious condition that can greatly affect a person's health and daily life if not
managed properly. This research uses advanced computer simulations and artificial intelligence to create
a digital heart model that quickly and accurately predicts how individual patients will respond to different
treatments. By enabling personalized therapies and providing faster insights into treatment outcomes, this
approach could improve patient care, lower healthcare costs, and enhance overall quality of life.